USHER SYNDROME--CLINICAL AND MOLECULAR STUDIES

The purpose of this project is to document the clinical features of Usher syndrome and to refine the localization and eventually to isolate the genes causing this disease.